DIRECT: Enhancing Bioethics Capacities at Kamuzu University of Health Sciences (KUHeS)

NIH/Fogarty International Research Ethics Education and Curriculum Development Award
(R25): DIRECT: Enhancing Bioethics Capacities at Kamuzu University of Health Sciences
(KUHeS)
ABSTRACT/PROGRAM SUMMARY
The overarching goal of our Developing Research Ethics Education and Curriculum Development
Award (DIRECT) is to collaboratively strengthen bioethics capacities at Kamuzu University of
Health Sciences (KUHeS) in Malawi through the development of a comprehensive and locally
administered Masters-level educational program targeting students and professionals in allied
health, medicine, nursing, pharmacy, biomedical research and other health-related disciplines. This
new program will build on current bioethics modules in the KUHeS flagship MPH program. The
curriculum will focus on the broad development of analytic skills related to the ethics of
implementation research health in resource-constrained settings, including associated ethical
issues in clinical care and public health practice. To ensure local relevance, the design and content
of the program’s educational modules will be collaboratively developed through Malawi-based
curriculum development workshops involving local collaborators, health professionals and
practitioners, policy-makers and students. An innovative feature of this program will be a focus on
the neglected issue of bioethics in mental health research, policy and practice, to be developed in
collaboration with the Department of Psychiatry and Mental Health at KUHeS. This program will
be reinforced and complemented by the supplementary aims of developing policy
recommendations for mental health research in sub-Saharan Africa, strengthening bioethics
teaching capacities of local faculty and former program students, publishing a casebook of
bioethics case-studies developed through the program, and disseminating bioethics and research
ethics news through a KUHeS Bioethics newsletter. We believe that a comprehensive and
collaboratively developed bioethics educational program, built on longstanding partnerships
between the leading Malawian health institutions and University of North Carolina-Chapel Hill,
will have a substantial impact on students, their future institutions, and the culture of health
research in the region.

Public health relevance
PROJECT NARRATIVE Through a partnership with The University of North Carolina at Chapel Hill and Kamuzu University of Health Sciences (KUHeS), we will expand research and bioethics programs at the Masters-level in Malawi. We will establish a comprehensive and locally-administered Masters Program in the School of Global and Public Health at KUHeS. We will also work in collaboraJon with the Department of Psychiatry and Mental Health and the Department of Health Systems and Policy to develop graduate level training in bioethics for mental health pracJJoners and researchers that examines the ethical, legal, and social issues related to mental health in Malawi and, more broadly, in Sub-Saharan Africa.